MARC at San Diego State University

PROJECT SUMMARY
A creative, innovative biomedical workforce depends on diverse teams lead by PhD scientists trained in technical
skills and culturally-aware people skills. The United States’ population of historically excluded groups, which
include those from underrepresented minorities (URMs), disadvantaged backgrounds, and/or those with
disabilities, is growing, corresponding to an increased interest in STEM fields. However, barriers to equity and
access have led to lower rates of entry into PhD programs and scientific careers by minoritized groups. With the
growing complexity and urgency of the health and well-being challenges facing our country, we simply cannot
afford to continue to exclude underrepresented groups from the research enterprise. Here, we propose to support
16 Maximizing Access to Research Careers (MARC) scholars at San Diego State University (SDSU) with
research-validated supportive programming and faculty-mentored research experiences to develop critical
thinking, communication, leadership, interpersonal, technical, and resiliency skills. All MARC experiences are
developed through a culturally aware lens that seeks to build scholars’ sense of belonging, support their mental
health and wellness, and provides a culturally congruent and scientifically stimulating academic home. Here, we
are building on 33 successful years of our SDSU MARC program by introducing new partnerships with campus
Cultural Centers and disability services for recruitment and programming synergy, introducing a new near-peer
mentoring program to combat barriers to success in graduate programs, providing dedicated mentor training
within a cultural context that empowers faculty mentors to promote the development, self-efficacy, and
independence of their MARC scholars, and responding to scholar needs with new programming. We continue to
use evidence-based evaluation data to improve our MARC and pre-MARC programming to prioritize student
success and support, which we intend will only grow our success of scholars entering and completing PhD
programs. Our workshops, panels, seminars, coursework, and socials have been developed to build critical
thinking and quantitative skills, oral and written communication, ethics, reproducibility and rigor, leadership,
mental health and resiliency, self-efficacy, and a sense of belonging. We assess all programming through
evaluation methods to ensure our program is always improving in terms of rigor, support, efficiency, and success
so that MARC scholars are prepared to enter and complete graduate programs. By leveraging key partnerships
at SDSU, we are able to synergize our infrastructure, programming, coursework, and mentorship relationships
so that we may expand our impact far beyond the requested 16 slots to provide instruction, discussion, and
inspiration for historically excluded STEM students and their allies across campus.

Public health relevance
PROJECT NARRATIVE Diverse teams of scientists are more likely to address issues of higher impact and complexity and produce more innovative and creative solutions. To ensure the robust health of the biomedical research enterprise, the SDSU MARC program seeks to identify and nurture the talent and potential of historically excluded students in science, technology, engineering, and mathematics (STEM). MARC scholars benefit from research-validated, supportive, and culturally aware programming and cutting-edge research experiences that prepare them for success in graduate programs and as future leaders in the biomedical workforce.